Modulation of Mcl-1 for Treatment of Lung Cancer

Summary
KRAS mutations activate Raf/MEK/ERK1/2 that can directly phosphorylate Mcl-1 at T163, enhancing Mcl-1’s
function. KRAS mutations also activate PI3K/AKT that can inactivate GSK-3 and inhibit GSK-3-mediated
pMcl-1 at S159 to reduce Mcl-1 degradation. We hypothesize that KRAS mutation-activated ERK1/2 and
PI3K/AKT pathways contribute to stabilization of Mcl-1 via upregulation of pMcl-1 at T163 and downregulation
of pMcl-1 at S159 in lung cancer. Our preliminary data show increased pMcl-1 at T163 in tumor tissues from
NSCLC patients, which associated with worse survival outcome, suggesting that pMcl-1 at T163 may provide a
new therapeutic target and a prognostic biomarker in NSCLC patients. We found that Mcl-1, in addition to its
canonical antiapoptotic function, plays a critical role in supporting homologous recombination (HR)-mediated
repair of DNA double-strand breaks (DSBs). Based on this novel function, we discovered an entirely new class
of small molecule Mcl-1 inhibitor, MI-223, that interacts with the BH1 pocket of Mcl-1 and inhibits HR activity.
MI-223 has potent anti-tumor activity against lung cancer in vitro and in vivo. Olaparib is an FDA-approved
PARP-1 inhibitor with anti-cancer efficacy; however, only patients with HR deficiency (e.g. BRCA1/2 mutations)
respond to olaparib therapy. Since MI-223 inhibits HR-mediated DNA repair, this provides a rationale for
combining MI-223 and olaparib to treat various cancers, including those without BRCA1/2 mutations.
Combined treatment with MI-223 and olaparib synergistically suppresses lung cancer growth in vitro and in
vivo. Since our data indicate that KRAS mutations can activate Mcl-1, we hypothesize that MI-223 alone or in
combination with olaparib may be effective against lung cancers with KRAS mutations. MI-223-induced DSBs
upregulate PD-L1 in tumor tissue from mutant KRAS driven lung cancer model, suggesting combination of MI-
223 with anti-PD-L1 may overcome PD-1 inhibitor resistance in KRAS-mutant lung cancer. To characterize and
develop this novel Mcl-1 inhibitor MI-223 for the treatment of lung cancer, we propose two specific aims: (1)
Determine whether and how KRAS mutations activate Mcl-1 leading to treatment resistance in human lung
cancer cells. Studies will determine whether pMcl-1 at T163 is a novel prognostic biomarker and therapeutic
target in patients with NSCLC; (2) Determine mechanism of action of novel Mcl-1 inhibitor MI-223 in killing
human lung cancer cells. Studies will test the potency of MI-223 alone or in combination with PARP inhibitor
olaparib in patient-derived lung cancer xenograft (PDX), radioresistant, and KRAS-mutant lung cancer
xenografts. Determine whether MI-223 synergizes with olaparib or anti-PD-L1 to more effectively suppress
tumor growth and prolong survival in genetically engineered mutant KRAS-driven lung cancer animal models.
By targeting Mcl-1, we expect to develop a new class of anti-cancer agents and combination strategies for lung
cancer treatment.

Public health relevance
Narrative Resistance to treatment and lack of targeted treatment options for KRAS mutations are two major clinical challenges in lung cancer therapy. A common link to these two problems is the activation of Mcl-1, a major antiapoptotic protein that is overexpressed in human lung cancer. Studies in this project will develop a novel Mcl-1 inhibitor with the goal of overcoming treatment resistance and treating lung cancer with KRAS mutations, which will have substantial impact for a large subset of patients with lung cancer.